Human adipose tissue in control of sympathetic tone and metabolic rate

ABSTRACT
Sympathetic outflow to adipose tissue regulates whole body energy homeostasis by stimulating lipolysis in
white adipocytes and thermogenesis in brown or beige adipocytes. Using a novel approach to study human
adipose tissue in mice [1, 2], we have found that, during development, human adipocytes express a high level
of monoamine oxidase A (MAOA), a major mechanism for degradation of norepinephrine, and a known
target of antidepressant drugs [3]. Notably, expression of Maoa is virtually undetectable in mouse adipocytes,
indicating that this control mechanism may have evolved to meet the metabolic features of larger species. We
find that human adipocyte MAOA is decreased during beige adipose tissue development, potentially increasing
norepinephrine bioavailability, adrenergic tone and thermogenic capacity. Thus, MAOA expression in human
adipocytes is a previously underappreciated, key mechanism controlling adipose tissue functions,
potentially underlying susceptibility to obesity and metabolic disease. In this proposal, we will further test
the hypothesis that adipocyte MAOA controls systemic energy homeostasis through its effects on adipose tissue
sympathetic responsiveness. We have developed methodologies to obtain large numbers of human multipotent
mesenchymal progenitor cells that can differentiate into multiple adipocyte subtypes, and can generate
functional adipose tissue upon implantation in vivo. We have also successfully deleted MAOA from these cells
using a novel nanoparticle-based, CRISPR-Cas9 protein delivery technique, resulting in a >90% depletion of
MAOA protein while avoiding non-specific effects of expressed Cas9. Leveraging these technologies, we
shall: Aim 1. Test the hypothesis that human adipocyte MAOA limits lipolytic and thermogenic responses to
norepinephrine. We will measure lipolysis and induction of thermogenesis in control and MAOA-deleted
human adipocytes exposed to norepinephrine, as well as steady-state norepinephrine levels and dependency on
the monoamine transporter Oct3. Aim 2. We will test the hypothesis that MAOA in human adipocytes
regulates the development and responsiveness of thermogenic adipose tissue in vivo. We will measure the
rate and extent of vascularization and innervation, and thermogenic responsiveness to environmental stimuli of
tissue developed in NSG mice from control or MAOA deleted human adipocytes. Aim 3. We will test the
hypothesis that expression of MAOA in adipocytes will determine susceptibility to obesity, systemic insulin
sensitivity and systemic glucose homeostasis. We will analyze weight gain, adipocyte size, insulin sensitivity,
glucose disposal under hyper insulinemic, hyperglycemic clamps, and basal metabolic rate in mice harboring
adipose depots formed from control or MAOA deleted human adipocytes, and in mice overexpressing MaoA in
subcutaneous adipose tissue. These aims will provide the basis for further development of tissue specific
MAOA-targeting strategies as novel therapeutics for metabolic disease.

Public health relevance
NARRATIVE There is a strong relationship between adipose tissue and the risk of diseases such as Type 2 Diabetes, fatty liver and heart disease. However, adipose tissue plays many beneficial functions, and healthy adipose tissue can actually protect from metabolic diseases. Adipose tissue health means that all the types of adipose tissues present in the body function correctly. During fasting, adipose tissue must be able to provide muscles, heart and liver with sufficient fuel to maintain blood glucose levels. Also, a distinct type of adipose tissue, called beige or brown, must be present to help control body temperature. Beige fat also has the capacity to burn calories and secrete hormones that improve metabolism. The proper functions of adipose tissues are controlled by the brain, which detects the need for fuel, or the outside environmental conditions. The brain communicates to adipose tissues via nerves, which secrete a neurotransmitter called noradrenaline. We have found that human fat cells have an enzyme, called MAOA, that can degrade noradrenaline. The levels of this enzyme in adipocytes can have a great impact on how the brain communicates not only to adipocytes, but to organs surrounded by adipose tissue such as the heart and major blood vessels. To study the importance of this enzyme we developed a unique model in which we can grow human fat in mice. Our current results suggest that MAOA in human adipocytes can control adipocyte beiging, and is therefore probably very important in controlling whole body metabolic rate. The studies proposed in this grant will determine whether human adipocyte MAOA can affect the levels of noradrenaline sufficiently to affect adipose tissue function and influence propensity for weight gain and glucose metabolism. If we find that human adipocyte MAOA is capable of affecting metabolic rate, we will design ways to target its activity to improve weight loss and ameliorate metabolic diseases such as type 2 diabetes, fatty liver and heart disease.